Translational Approach to Studying miRNA functions in sACC and amygdala in patients with BPD

Abstract:
Bipolar disorder (BPD) is a severe mental disorder with a significant burden on public health. MiRNAs are
highly expressed in the brain and have been shown by us and others to play a role in the neuropathology of BPD
and other psychiatric disorders. However, to date, all published postmortem brain miRNA expression studies of
BPD have been hampered by small sample sizes, older detection platforms, and a lack of comprehensive data
integration with other genomic resources.
To address these limitations, we propose a translational approach that will apply miRNA sequencing in the
amygdala and subgenual cingulate anterior cortex (sAAC) in 150 patients diagnosed with bipolar disorder and
matched 150 neurotypical controls, followed by a replication study in an independent sample of 100 matched
case/control sample. Our aims are designed to take full advantage of this large and exceptionally well clinically
characterized sample. With our large discovery and replication samples, we are powered to identify moderate to
small effect sizes typically observed in neuropsychiatric disorders. By leveraging other pre-existing genomic
datasets (i.e., GWAS data and RNA-seq) generated in our sample, we will apply a state-of-art series of
bioinformatic and statistical approaches for the comprehensive integration of these genomic data. This
integration will lead to the generation of specific and testable hypotheses. As an example, integrating the miRNA-
seq data with GWAS of BPD (from the Psychiatric Genomics Consortium) will reveal the genetic mechanisms
by which genome-wide significant risk variants contribute to the etiology of bipolar disorder, e.g., variants
affecting miRNA expression between BPD cases and controls. Integrating the miRNA-Seq and RNA-Seq data
will identify miRNA gene targets with important functions in the etiology of bipolar disorder. Finally, we will identify
a set of high confidence risk miRNA of BPD (i.e., miRNAs with convergent evidence from the discovery, eQTL,
bioinformatic, and replication analyses) and deliver these in mice models to delineate the disease-specific
functions and roles these miRNA play in BPD neuropathology.
In summary, the neurobiological mechanisms by which polymorphisms associated with BPD increase the risk
for bipolar disorder are unknown. We hypothesize that one of the mechanisms contributing to the neuropathology
of BPD is the ability of risk BPD variants to affect miRNA expression. Using such large discovery and replication
brain samples of BPD, we will identify miRNA, whose expression is robustly associated with bipolar disorder and
under the control of risk variants for BPD and further validate their disease functions by testing their impact on
behavioral measures in mice models.

Public health relevance
Narrative: The goals of this application are: 1) identify miRNA differentially expressed in amygdala and subgenual anterior cingulate cortex between subjects with BPD and matched neurotypical controls in a large discovery and replication samples of BPD (N=300 and N=100, respectively); 2) uncover the genetic mechanisms by which genome-wide significant polymorphisms from GWAS of BPD affect miRNA expression in these two brain regions; 3) test the functional effect of a selected set of miRNA in mouse models to investigate BPD-like behavioral measures.